REGULATORY ROLE OF CALCITONIN GENE RELATED PEPTIDE

The role of CGRP in regulating human parturition will be evaluated through the examination of CGRP induced relaxation response and receptor binding from myometrial specimens obtained during C-sections.